Development of a Wearable Fluorescence Imaging Device for IntraoperativeIdentification of Brain Tumors

ABSTRACT
Approximately 700,000 people in the United States are diagnosed with a primary brain tumor. Of these, malignant
gliomas (MGs) account for approximately 40% of all intracranial tumors, with an overall survival rate of only
~34%. Surgical resection remains the cornerstone of therapy and the extent of resection correlates with survival.
Fluorescence imaging has emerged as an adjunctive technique, allowing for real-time cancer-specific detection.
Surgeries guided by fluorescence imaging achieve gross-total-resection (GTR) rates of 75-100%, which are
significantly higher than conventional surgeries with GTR rates of 30-55%. However, most clinical-grade imaging
systems are hampered by high costs, limited portability, and lack of operation flexibility. Some neurosurgical
fluorescence microscopes cost upwards of ~$500K and weigh ~800 pounds (PENTERO® 900 with fluorescence
kits, Carl Zeiss). Many surgeons prefer, and continue to use wearable surgical eye loupes, which allow for
convenient and fast operation, but are not capable of fluorescence visualization. Supported by the STTR Phase
1 Award (R41CA243600) and Kentucky State Matching Fund, Bioptics Technology (BOT) has developed a low-
cost wearable FLoupe™ device (US Patent Application #62/530,613, 2017) attached to surgical eye loupes for
intraoperative identification of fluorescent MGs. We have tested FLoupe™ prototypes to image fluorescent MGs
during surgery in a small group of patients. Comparable results are observed against the PENTERO® 900
system. Based on neurosurgeons’ feedback in Phase 1, this Phase 2 project will further optimize the headlights
(LEDs), video camera, emission filters, electrical control system, and mechanical design of the FLoupe™ device
in terms of weight, size, imaging quality, and ease to wear/operate (Aim 1). The optimized FLoupe™ device will
be calibrated and validated against the PENTERO® 900 system for equivalence to image fluorescent MGs in a
large group of patients (Aim 2). We expect that fluorescence images taken at the surgical site and from biopsied
samples by both devices will be equivalent and agree with the blinded histopathological analyses (the gold
standard). Resulting data will be used for FDA clearance via the pre-market notification 510(k) submission with
the PENTERO® 900 system as the primary predicate. Compared to the PENTERO® 900 system, the FLoupe™
device is significantly less expensive (<$10K unit sale price), more compact (wearable), and easier to operate
(hand free with wireless control). This affordable and wearable device will significantly increase the ability of
neurosurgeons to conduct fast and thorough operations, thus improving patient safety and outcomes. At the end
of this Phase 2, a clinical-grade FLoupe™ device will be generated as a pre-manufactured product for
intraoperative identification of MGs. Moreover, the FLoupe™ device with a modular design is easily modified
with optimized excitation lights and emission filters to image a variety of visible dyes (e.g., fluorescein, 5-ALA,
methylene blue). Thus, our product has the potential to be incorporated in other surgical settings beyond brain
tumor resection based on the fluorescence characteristics of cancers, thereby expanding its market share.

Public health relevance
PROJECT NARRATIVE Fluorescent imaging of cancers during surgery allows real-time cancer-specific detection for guiding tumor removal, often resulting in significant improvements in patient survival; however, it is hampered by large expensive equipment. Bioptics Technology (BOT) is developing an innovative, low-cost, wearable fluorescence imaging device (FLoupe™, BOT brand) that attaches to standard surgical eye loupes to help neurosurgeons easily and accurately identify brain tumors for safe and maximal removal. This affordable and wearable device will significantly increase the ability of more surgeons to conduct fast and thorough operations, and thus improving patient safety and outcomes.